Developing Methanosarcina spp. as a model system to study cytochromes c and their role in archaeal methane metabolism

Project Summary/Abstract
No Changes from Parent Award

Public health relevance
Project Narrative No Changes from Parent Award